Epidemiology and Population Genetics of Malaria Parasites in Kenya

Project Summary
Scale-up of vector interventions, improved diagnosis, and effective treatment have collectively contributed to
significant global reductions in malaria mortality and morbidity over the last 15 years. Nevertheless, malaria
burden remains high in sub-Saharan Africa, which reported 215 million cases and 380,000 deaths in 2019.
Malaria burden reduction is not uniform, with some countries or regions continuously exhibiting high incidence
whereas others show drastic reductions. Consequently, many African countries have proposed sub-national
stratification of malaria risk and have developed corresponding surveillance and intervention plans to target
heterogeneous malaria burden. As the prevalence of clinical malaria cases decreases, transmission becomes
more focal and the proportion of malaria infections that are asymptomatic increases. Asymptomatic cases
typically go undetected and untreated. They constitute an obscure parasite reservoir, silently sustaining
transmission and threatening malaria control and elimination efforts. Functional and responsive malaria
surveillance systems are necessary for quantifying the true burden of disease, identifying residual transmission
foci for targeted control, and evaluating the effectiveness of interventions. Enhanced surveillance methods and
more sensitive malaria diagnostic methods are needed to detect symptomatic and asymptomatic infections in
low-transmission settings. The central objective of this F31 application is to examine the spatial and
genetic epidemiology of malaria parasites in low-transmission regions in Kenya in the context of rapidly
declining transmission following the implementation of intensive control programs. I will examine the
effectiveness of hospital-based clinical malaria cases and reactive case detection methods in transmission
hotspot detection (Aim 1), and investigate the genetic connectivity and diversity of malaria infections within and
among clusters of malaria cases using amplicon deep sequencing and microsatellite typing (Aim 2). Identification
of transmission hotspots will inform malaria intervention strategies best suited to local epidemiological contexts.
Patterns of genetic connectivity among parasite isolates will reveal the geographical spread and transmission
network of malaria infections. These data will improve our understanding of malaria epidemiology in settings
where transmission is rapidly declining, thus guiding decision-makers in tailoring optimal strategies to achieve
local malaria control and elimination goals. This proposed research will have broad implications for malaria
surveillance in other areas of Africa that are experiencing significant reductions in malaria transmission. Under
the mentorship of a multidisciplinary team, I will gain skills in infectious disease epidemiology, spatial
epidemiology, molecular population genetics, and bioinformatics while developing leadership and professional
skills that are necessary to prepare me for a career as an independent global health researcher and infectious
disease epidemiologist.

Public health relevance
Project Narrative Malaria remains a major public health problem in Kenya, where progress towards malaria elimination has stagnated and the threat of disease resurgence persists. Enhanced epidemiological surveillance systems are needed to identify foci of transmission for targeted malaria control and to evaluate the effectiveness of malaria control programs. In settings of rapidly declining transmission, where asymptomatic infections predominate and silently sustain transmission, high-resolution spatial and epidemiological data are particularly needed to inform the development of optimal malaria control strategies aimed at eliminating transmission reservoirs.